The importance of Lysyl Oxidase in Atherosclerosis

Abstract
This F32 fellowship award aims to facilitate the training and career transition of Dr. Filipe Fernandes Stoyell-
Conti, Ph.D., an outstanding minority candidate, in vascular biology and atherosclerosis. Specifically, the grant
offers to Dr. Fernandes Stoyell-Conti the possibility of improving his hands-on skills in the laboratory,
strengthening his critical thinking and advancing his knowledge in bioinformatics and vascular biology. He will
receive training while investigating the role of lysyl oxidase (LOX), a copper-dependent amine oxidase, in smooth
muscle cells (SMCs) biology and atherosclerosis. Dr. Fernandes Stoyell-Conti research hypothesis is that LOX
facilitates SMC cell migration, inflammation, and foam cell formation during atherogenesis. In three specific aims,
he will: 1) investigate whether inactivation of LOX in SMCs compromises in vivo phenotypic switch of SMC, 2)
demonstrate that expression of LOX in SMC increases atherosclerosis in hyperlipidemic mice, and 3) examine
the molecular mechanisms by which LOX changes gene expression in SMCs. He will combine state of the art
animal models, transcriptomics (RNA-seq) and molecular biology to demonstrate that LOX can “turn off/on” gene
transcription in SMCs to make them more atherogenic. Together, these studies will advance his knowledge about
LOX's role in atherosclerosis and facilitate his transition towards independence as principal investigator in the
field of vascular biology and cardiovascular disease.

Public health relevance
Project Narrative Atherosclerosis is the leading cause of death and disability in the Western world, however, the mechanisms underlying atherosclerosis are complex and remain obscure despite intense research in this area. I propose to establish for the first time the cause-and-effect relationship between the enzyme lysyl oxidase and atherosclerosis using unique animal models developed by our team. This study could provide new therapeutic treatments that reduce the risk of developing cardiovascular diseases.